Trapped Ion Mobility Spectrometry Quadrupole Time-of-Flight System

Project Summary
Oregon State University is requesting funds for adding a trapped ion mobility spectrometry
quadrupole time-of-flight (timsTOF) LC-MS system with MALDI imaging capability to advance
biomedical research at Oregon State University (OSU) and in the State of Oregon. The new
instrument will catalyze OSU's “ONE Health” research initiative, promoting collaborative and
trans-disciplinary research in human, animal and environmental health to increase our knowledge
of the underlying causes of human diseases, contribute to discovery of new diagnostic markers
and innovative therapies. The proposed Bruker timsTOF fleX MS system will allow Oregon's
research community - for the first time - to conduct MALDI imaging mass spectrometry and spatial
“omics” to accelerate progress in ongoing projects related to the “One Health” paradigm. The
requested equipment will enhance capabilities in small molecule omics by providing access to
high-resolution ion mobility mass spectrometry and CCS determination, enabling compound
identification and 4D “omics” (RT, mass, MS2 and CCS). Increased measurement sensitivity and
the advanced timsPASEF acquisition mode will enable nano-scale LC-MS based “omics” for
amount-limited samples and laser-capture microdissected tissues. An innovative HESI source will
advance our capabilities to provide comprehensive plasma lipidomics. The proposed equipment
will replace 12-year old qTOF systems in OSU's mass spectrometry center (OSU MSC). The OSU
MSC has provided a collaborative research and inclusive training environment since 1973. As
university core facility, the OSU MSC has institutional support from the research office and
multiple colleges, which ensures a high level of financial and operational stability. The OSU MSC
is directed by faculty with indefinite tenure. Two full time employees ensure a high level of
technical competency and consistency in the maintenance and operation of the equipment,
associated workflows and data management. Research associates provide support to research
projects and assist in training of students and users. An internal oversight committee will
coordinate use of the requested equipment and administration of policies. Research topics include
metabolic diseases, vascular cognitive impairment and neurodegenerative diseases, botanical
supplements to promote resilience in aging and zebrafish as whole system model in toxicology.
A pilot and feasibility program will promote the new measurement capabilities and MALDI imaging
mass spectrometry. The new equipment will enhance statewide efforts of the major research
universities, centers and institutions in Oregon to coordinate and foster inter-institutional research
and training in the biomedical sciences.

Public health relevance
Project Narrative The requested trapped ion mobility quadrupole time-of-flight mass spectrometry system will catalyzed research aligned with the “ONE Health” theme. The requested instrument will promote collaborative and trans-disciplinary research in human, animal and environmental health to increase our knowledge of the underlying causes of human diseases, and contribute to the discovery of new diagnostic markers and innovative therapies. The new equipment will enable “spatial omics” by MALDI imaging mass spectrometry and advanced acquisition modes will allow measurements of molecules in complex biological matrices with high specificity and sensitivity over a wide dynamic range.